Bayesian methods for cortical surface neuroimaging data

PROJECT SUMMARY: Over the past several decades, non-invasive functional magnetic resonance imaging
(fMRI) has revolutionized the study of brain function and organization, enhancing scientific understanding of
normal brain function, development, aging and disease. Yet leveraging the full potential of fMRI data remains
challenging due to its massive size, complex dependence structure and noise. Analysis of individual subjects,
which is needed for clinical care and the study of brain-behavior relationships, is particularly difficult due to high
noise levels and typical short scan durations. Traditional analysis techniques were originally developed with
computational feasibility in mind, rather than optimal efficiency and power. Today, statistical, computational and
data advances provide opportunities for development of statistical methods with substantially improved accuracy
for group and individual fMRI analysis. In particular, cortical-surface fMRI (csfMRI) data, an increasingly popular
format in which the cortical gray matter is projected to a 2-dimensional manifold, offers two important benefits.
First, geodesic distances along the cortical surface are a meaningful measure of dissimilarity in neuronal
activation, unlike Euclidean distances in traditional volumetric fMRI data, making csfMRI optimal for use in spatial
models. Second, csfMRI data achieves more accurate alignment of subjects' cortical areas, thus improving the
precision of group studies and providing an opportunity to borrow strength across subjects. This project focuses
on the development of computationally efficient Bayesian statistical methods for csfMRI data. We address two
specific scientific objectives: (1) estimation of activation in the brain in response to a task or stimulus, and (2)
identification of functional areas of the brain, which tend to activate together in the absence of a particular task.
For (1), we propose a spatial Bayesian model that addresses the limitations of previously proposed models by
(a) utilizing csfMRI data rather than volumetric fMRI, (b) employing recent developments in spatial statistics and
Bayesian computation for accurate and efficient model estimation, (c) utilizing an efficient excursions set method
to identify areas of activation based on the joint (rather than the marginal) posterior distribution, and (d) proposing
an efficient and principled multi-subject analysis approach. We also propose several extensions to allow for
spatial dependencies that are not stationary and isotropic. For (2), we propose a hierarchical Bayesian
independent component analysis (ICA) model that borrows strength from the population through empirical priors,
which are estimated from large, publicly available fMRI datasets. The use of empirical priors is very
computationally advantageous. Finally, we combine this model with the proposed spatial Bayesian approach to
task activation developed for Aim 1 by incorporating a spatial prior appropriate for csfMRI data into the
hierarchical ICA model. We conduct simulation and reliability studies to validate the proposed methods and
compare them with traditional approaches. We also apply the proposed methods to studies of autism spectrum
disorder and amyotrophic lateral sclerosis or Lou Gehrig's disease.

Public health relevance
PROJECT NARRATIVE: Compared with traditional volumetric functional magnetic resonance imaging (fMRI), cortical surface fMRI offers superior alignment of subjects' cortical areas and more meaningful spatial modeling through neurologically relevant geodesic distances along the cortical surface. We propose some of the first advanced statistical methods for cortical surface fMRI data, with a focus on computationally efficient Bayesian techniques. The proposed methods have the potential to impact other fields where the utilization of Bayesian methods has been limited due to computational challenges posed by high-dimensional data, such as genomics and astronomy.